PESTICIDES AND RISK IN THE AGRICUTURAL HEALTH STUDY

DESCRIPTION (Taken from the Investigator's Abstract) The long term, goal of this research is to elucidate the cause(s) of Parkinson's Disease (PD) with a focus on environmental determinants. The investigators propose to investigate the relationship between PD and exposure to pesticides and other factors by conducting a nested case-control study in the Agricultural Health Study (AHS), using a 3:1 case-control ratio and employing classical methods for multi-variate analysis. There are 2 primary aims. Aim 1 will test the hypothesis that pesticide exposure increases PD risk using self-report (life history) and direct (blood, dust) measurements. Aim 2 will test the hypothesis that other (nonpesticide) chemical exposure increases PD risk, using a job-task-based occupational history, and blood testing. Three secondary aims: 1) will test the hypothesis that the soil pathogen Nocardia asteroides causes PD using a battery of assays in blood, soil and dust (aim 3); 2) will assess the role of specific lifestyle and health factors previously reported to alter PD risk (aim 4); and, 3) will assess the effect of specific polymorphisms of xenobiotic metabolizing, genes previously associated with PD on disease risk (aim 5). The studies proposed take full advantage of the AHS, a unique, prospectively studied cohort. The investigators believe that this work could provide a critical and dramatic next step in furthering our knowledge of environmental determinants of PD, and thereby take us closer to our goal of finding its cause(s).